XRAY SOLUTION SCATTERING OF DNA VIRUSES

Our long term goal is to determine the molecular structures of DNA-containing viruses such as P22 bacteriophage and herpes simplex virus type 1 capsid which have diameters of 600 [unreadable] and 1,250 [unreadable], respectively. Our primary structural tool is electron cryomicroscopy and computer reconstruction and the resolution of the reconstruction is targeted to beyond 10 [unreadable]. The electron imaging technique has an intrinsic inaccuracy of measuring the amplitudes of the structure factors due to the microscope instrumental factors. This proposal is aimed at using X-ray solution scattering to provide the scattering amplitudes of these viral capsids at a broad range of frequencies from 1/1000 to 1/10 [unreadable]-1. These measurements will be used to correct those computed from the electron images of the corresponding capsids.